Microbiomal Mediators of TL1A-induced-Fibrosis

ABSTRACT
Inflammatory Bowel Disease (IBD) results from a series of complex interactions between susceptibility and
severity genes, the environment and the mucosal immune system, presenting as clinical disease. The gut
microbiome contributes to IBD; altered gut microbial composition has been demonstrated in intestinal
inflammation, but few studies have examined intestinal fibrosis. A vast number of potential genetic, epigenetic
and microbiotic variables contribute to the severity of IBD phenotypes. Among these, relatively clear, clinically-
identifiable phenotypes are those with a distinct, severe, fibrosing Crohn’s disease presentation. The
gene/protein combination of tumor necrosis factor superfamily (TNFSF) member 15 and tumor necrosis factor-
like (TL) cytokine 1A (referred to as: TNFSF15/TL1A) influences the severity of inflammation and fibrosis in both
animal models and human disease. My recently published findings have implicated the gut microbiome in
intestinal fibrosis, and on which TL1A depends to exert its pro-fibrotic effects. The precise mechanisms and
specific microbial contributors to intestinal fibrosis have yet to be elucidated, however. As fibroblasts are a
predominant cell type responsible for fibrosis, the mechanisms by which TL1A and microbiota drive intestinal
fibrosis likely involve direct induction of fibroblast activation, as my preliminary data demonstrates. I hypothesize
that TNFSF15/TL1A plays a central role in the induction and amplification of fibrosis by altering the microbiome
to enhance fibrosis-promoting microbial populations and through the direct activation of fibroblasts to express
fibrosis-related factors and/or to become more susceptible to microbial stimulation. In Aim 1, I will determine
whether TL1A-induced fibrosis in mouse models or TNFSF15-genetic risk in Veterans with Crohn’s disease is
associated with alterations in the microbiome. I will characterize the gut microbiome as assessed by 16S rRNA
sequencing of stool and tissue specimens from patients with and without TNFSF15-genetic risk. To confirm the
causal efficacy of these correlated organisms, WT and TL1A-transgenic germ-free C57/BL6 mice will be
colonized with the candidate bacterial consortia to evaluate for development of fibrosis in vivo. These microbiota
will also be characterized using metabolomic methods to allow more specific insight into their role in disease
pathogenesis. In Aim 2, I will characterize the TL1A-responsive effects and molecular mechanisms of direct
bacterial products and metabolites identified in Aim 1 on fibroblasts using primary isolated fibroblasts in vitro. In
Aim 3, I will determine if specific bacterial metabolites can causally mediate intestinal fibrosis in vivo using
selective administration in engineered mouse models. The results of this proposed study will provide insight into
the specific microbes, or their products, that drive intestinal fibrosis in concert with TL1A. If host-microbiome
interactions and resulting pro-fibrotic fibroblast phenotypes can be mitigated by manipulation of TL1A or the
microbiome/metabolome, intestinal fibrosis may be pre-empted in genetically susceptible individuals. These
investigations may thus reveal additional downstream pathways, molecules, and potential targets for therapy.

Public health relevance
PROJECT NARRATIVE Inflammatory Bowel Disease presents a significant burden for the VA Healthcare System and intestinal fibrosis is among its most consequential complication. Because the underlying mechanisms of fibrosis are poorly understood, fibrotic diseases have few effective treatments. In this proposal, I will study the microbiome of Veterans with Crohn’s disease in the context of genetic risk predisposing to intestinal fibrosis. Germ-free mice will be colonized with correlated bacteria to investigate the effect of the microbiome and its products on intestinal fibrosis. In vitro studies will probe the molecular mechanisms involved in these effects. The present proposal will use a comprehensive experimental approach to study mechanistically the interplay between genetic predisposition and microbiome in propagating the development of intestinal fibrosis in IBD. Thus, the most translatable outcomes of the findings from this proposal could be the identification of one or more therapeutic targets important to both inflammatory bowel disease in particular, and to end-organ fibrotic processes in general.